Inhibiting Cell Death for Protecting Cardiac Injury

PROJECT SUMMARY
The death of cardiomyocyte following myocardial infarction (MI) is one of the main causes of heart failure
and patient mortality. Our group previously identified MG53, a member of the TRIM family protein (TRIM72), as
an essential component of the cell membrane repair machinery. Mice without the mg53 gene develop
pathology in the heart and are susceptible to cardiac injury, while transgenic mice with increased levels of
MG53 (ctPA-MG53) are resistant to stress-induced MI, supporting the function of MG53 in cardioprotection.
Using CRISPR-Cas9 mediated gene knockout and live cell biotin proximity-labeling assay, we identified RIPK1
as a novel molecular partner of MG53 following I/R induced cardiac injury. RIPK1 is a key factor of necroptosis,
a programmed necrosis, which hasn’t been extensively studied in MI. In vitro cell culture studies with human
induced pluripotent stem cells (hiPSCs) and in vivo murine MI studies demonstrated that necroptosis plays an
important role in injury induced cardiac cell death. More importantly, following MI, mg53-/- hearts had higher
level of necroptosis, while ctPA-MG53 hearts displayed lower level of necroptosis than those of wild type
littermates, indicating MG53 could potentially regulate necroptosis. Indeed, biochemical experiments revealed
that wild type MG53 serves as an E3 ligase of RIPK1 following MI, while mutant MG53 without E3 ligase
function failed to target and mediate degradation of RIPK1. This research is centered on testing the
hypothesis that MG53 plays a critical role in inhibiting necroptosis via directly interacting with and destabilizing
RIPK1, targeting this functional interaction could be important for maintaining myocardial homeostasis and
developing effective treatments for cardiac diseases”. We will test the hypothesis with two specific aims. Aim 1:
Dissect the molecular mechanisms underlying MG53-mediated myocardial protection through regulating RIPK1
or other necroptotic factors. Aim 2: Define the function of MG53-mediated necroptotic inhibition for protection of
myocardial injury. Live cell imaging, CRISPR-Cas9 mediated gene editing in hiPSCs, AAV mediated gene
delivery and mutagenesis approaches will be utilized to dissect cellular and molecular functions of MG53 on
regulation of necroptosis. Overall, knowledge gained from this project will extend our current understanding of
MG53 as a membrane repair factor to its function for regulation of cell death following MI, and may have
potential translational implications for developing new therapeutic strategies for treating MI.

Public health relevance
PROJECT NARRATIVE Ischemic heart disease is a major threat to the public health in US and around the world. By using biochemistry, cell and molecular biology, genome editing and in vivo animal models, our proposed studies should provide critical insights into the biology underling cell death pathways following myocardial infarction, which could be targeted for treating ischemic heart disease.